EFFECTS OF OVERNIGHT INSULIN INFUSION IN INSULIN ACTION IN NIDDM

The purpose of this study is to determine whether changing glucose concentration during the night changes insulin action on the liver.